Understanding and optimizing the potential public health impact of a gonococcal vaccine

Neisseria gonorrhoeae (Ngo), the causative agent of the sexually transmitted infection (STI) gonorrhea, is a
major public health problem worldwide. The clinical outcomes of gonococcal infection range from asymptomatic
infection to severe sequelae that include pelvic inflammatory disease, adverse pregnancy outcomes, neonatal
complications and infertility. Infection with Ngo also increases the risk of acquiring and transmitting HIV. The
increasing incidence of gonococcal infection and the emergence of multidrug resistant ‘superbug’ strains of Ngo
make it clear that a vaccine-based intervention is urgently needed.
In this project our overall goal is to gather the data required to understand any potential barriers to the
widespread implementation of a gonococcal vaccine, to determine what information might increase uptake, and
to identify the vaccine features and vaccination strategy that will have the maximum impact on reducing the
prevalence of gonorrhea.
These studies are highly significant given that the ability to rapidly evaluate and implement a gonococcal
vaccine, once available, is essential.
The specific aims are:
AIM 1: Describe the distribution and transmission of Ngo with different phenotypes, and determine variability
among vaccine targets.
AIM 2: Among various populations, describe understanding of gonococcal disease and perceptions of risk as
well as assess acceptance of a gonococcal vaccine.
AIM 3: Model the potential impact of different vaccine formulations and different target populations to guide
gonococcal vaccine development and implementation.